Quantifying and improving radiotherapy outcomes among Veterans

For more than a century, radiation has been used as an effective therapeutic modality
for many different cancers and other diseases. Today, radiation therapy is clinically indicated for
more than half of all cancer patients, with the ability to provide cure, local or regional control,
and symptomatic palliation depending upon the clinical context. However, radiation can leave a
lasting mark on the normal tissues left behind. In particular, it has long been known that ionizing
radiation can promote cancer in otherwise normal tissue. While it is relatively rare for an
individual to develop a secondary malignancy (radiation-induced cancer following treatment for
a separate cancer), actual estimates of this rate vary widely according to different studies.
Furthermore, patient-level discussions of secondary malignancy rates are understandably
variable, neglect any understanding of the role of radiation dose or treatment site, and are
generally universal assumptions not tailored to the disease or the patient themselves.
My goal is to better understand the individualized risk of cancer induced by ionizing
radiation. My central hypothesis is that individual genetic variability is likely to modify the risks of
radiation-induced malignancy. However we have poor quantitative insights and an overall
incomplete picture of the identity, nature, and effect size of genetic determinants of these risks.
The ultimate goal of this proposal is to develop improved risk prediction frameworks
incorporating prospective genetic stratification. This would be invaluable for treatment-related
clinical decision-making, patient counseling, and tailoring post-radiation screening paradigms.
I plan to test my central hypothesis by pursuing the following three Specific Aims:
Aim 1. Identify a high-confidence cohort of Veterans receiving radiation therapy
Aim 2. Characterize second and secondary malignancy rates within the VA
Aim 3. Quantify genetic risk factors of radiation-induced secondary malignancies
To accomplish these aims, I will first implement, validate, and apply automated dose
quantification tools to national-level cohort data from the VA Corporate Data Warehouse (CDW),
to extract radiotherapy details such as date, modality, dose, and fractionation, among other
clinically important radiotherapy treatment variables. I will then identify new cancer diagnos(es)
following initial cancer treatment and perform propensity matching of second cancer risk for
Veterans exposed or unexposed to radiotherapy. Moreover, I will quantify second and
presumed secondary malignancy rates among individuals as a function of estimated integral
radiation dose. Using genetic data from the Million Veteran Program (MVP), I will measure
enrichment and potential functional significance of genetic variants among a cohort of Veterans
with radiation-induced secondary malignancy. I will also identify putative DNA repair defects and
other rare variants in known cancer predisposition genes among Veterans with second cancers.
My completion of the research described in Aims 1, 2 and 3 is expected to establish a
detailed understanding of genetic risk factors for radiation-induced malignancy. Moreover, these
Aims will establish a highly valuable cohort of veterans with curated radiotherapy and secondary
malignancy information, along with corresponding germline genetic data. Ultimately, these
resources and results are expected to have a profound impact on current radiation risk
assessment frameworks, by deepening our understanding of the interplay between individual
genetics and personalized risks.

Public health relevance
For more than a century, radiation has been used as an effective therapeutic modality for many different cancers and other diseases, and is clinically indicated for more than half of all cancer patients. However, it has long been known that ionizing radiation can also promote cancer in otherwise normal tissue. While it is rare for an individual to develop a radiation- induced cancer, actual estimates of this rate vary widely according to different studies. Moreover, we have a poor understanding of individualized risk and, in particular, the role that personal genetics may play in determining relative risk of developing a radiation-induced cancer. My research aims to 1) identify a high-confidence cohort of Veterans receiving radiation therapy, 2) characterize second and secondary malignancy rates within the VA, and 3) quantify genetic risk factors of radiation-induced secondary malignancies.